Core B: Clinical Core

CLINICAL CORE: CORE B - PROJECT SUMMARY/ ABSTRACT
The Clinical Core (Core B) of the Johns Hopkins Alzheimer's Disease Research Center (JHADRC) has seven
specific aims, including: (1) to recruit and follow a diverse cohort of subjects, working with the Outreach
Recruitment and Engagement Core (Core E); priority will be given to maintaining approximately 30%
representation of minorities, primarily African-Americans, among the study subjects; (2) to perform annual
standardized medical, neurologic, psychiatric and neuropsychological evaluations of the participants enrolled in
the JHADRC, (3) assist the Biomarker Core (Core F) in collecting and storing blood and cerebrospinal fluid
(CSF) specimens and magnetic resonance imaging (MRI) scans from JHADRC participants, (3) to provide
well-characterized subjects to IRB-approved research associated with the JHADRC, (4) working with the
Neuropathology Core (Core D), to maintain a high autopsy rate (>70% of deceased autopsied), (6) to
participate in collaborative research with other ADRCs, including multi-center research related to ADRD, and
(7) working with the Data Core (Core C) and the Biomarker Core, share clinical data, brain images and
specimens with the National Alzheimer Coordinating Center (NACC) and the National Centralized Alzheimer's
Disease Repository (NCRAD). Through these efforts, Core B strives to: (1) support investigators associated
with the JHADRC with key resources, (2) promote new and expanded research activities locally and nationally,
and (3) facilitate training of young investigators, including those supported through the Research Education
Component (REC).